Synthetic Methods to Make Emerging Fluorinated Groups More Accessible

PROJECT SUMMARY/ABSTRACT
Considering 20-25% of pharmaceuticals on the market today contain one or more fluorine atoms in their
active ingredient (several of which appear on the WHO’s List of Essential Medicines), it is evident that fluorine
chemistry continues to have a profound impact on drug development. Yet, despite the indisputable significance
of fluorine atoms and fluorinated groups in modern medicinal chemistry, there has been a historical lag in their
implementation in pharmaceuticals over the last century. The reason for this lag can most often be attributed to
synthetic accessibility, as methods to install fluorine on molecules have been notoriously reliant on hazardous
reagents, e.g., F2 and HF. While methods to incorporate, for instance, CF3, OCF3, and SCF3 groups on complex
molecules have become far safer and more accessible in the last few decades (and these groups have since
become commonplace in drug design), there remain a number of fluorinated groups with untapped potential that
cannot be easily synthesized yet. This proposal specifically identifies the SF5, N(CF3)2, and N(CF3)(CF2H) groups
as desirable motifs that have demonstrated promise yet continue to be underemployed due to the fact that there
are virtually no user-friendly methods to make them.
Accordingly, the proposed work is centered on addressing the synthetic chemistry bottlenecks that are
preventing the realization of applications of these fluorinated groups. For one, the SF5 group has been studied
as a bioisosteric replacement for a CF3 or t-Bu group, but only aryl-SF5 compounds have been made available
commercially. Given the recent increase in accessibility of SF5Cl, we can now envision ways to expand the
realm of possibility in C(sp3)–SF5 bond formation. Specifically, SF5 radical chemistry can be merged with strain-
release functionalization to form novel “hybrid bioisosteres” that add another dimension of flexibility in molecular
design. Methods are also envisioned to synthesize and examine some of the first benzylic-SF5 compounds, as
well as other potential building blocks for the medicinal chemistry toolkit. The N(CF3)2 group (notably distinct
from N–CF3) is arguably even less accessible/explored than the SF5 group, but it has demonstrated promise as
a lipophilic NO2 group alternative. While all known methods make this group to date strictly require F2 or aHF,
our approaches seek reasonable ways to circumvent these reagents altogether. This will make the N(CF3)2
group available to a significantly broader community of scientists. Lastly, the N(CF3)(CF2H) group is evidently
the least accessible of them all, but it is liable to be an interesting alternative to the N(CF3)2 group with its added
ability to serve as a lipophilic hydrogen-bond donor. We have envisioned ways to make this that avoid the current
reliance on toxic SF4 gas. In all, safer methods to make the SF5, N(CF3)2, and N(CF3)(CF2H) groups will enable
the study of their physical properties and how to leverage them in the design of potential drug candidates.

Public health relevance
PROJECT NARRATIVE While fluorinated functional groups have become a hallmark of the modern medicinal chemist’s toolkit, there remain a number of groups – e.g., SF5, N(CF3)2, and N(CF3)(CF2H) – with demonstrated potential that are counterintuitively underemployed. The source of the problem is that all known methods to make these groups require extremely harsh reagents and reaction conditions; that is, the apparent bottleneck in realizing their utility in biological applications is overcoming the vertiginous challenge of chemical accessibility. Accordingly, the proposed research focuses on developing user-friendly synthetic methods to make the SF5, N(CF3)2, and N(CF3)(CF2H) groups more readily available to a broader community of scientists, ultimately to enable downstream applications in drug design.